Uncovering the Role of RNA Modifications in the Paraspeckle

PROJECT SUMMARY
RNA modifications are chemical changes made to transcripts that can regulate their processing, structure, and
stability. Recent advances in modification detection techniques have revealed the presence of RNA
modifications in mRNA and lncRNA, expanding the known regulatory potential of these modifications beyond
their canonical roles in tRNA and rRNA. RNA modifications have been found to modulate the expression of
oncogenes and tumor suppressors alike, demonstrating the need to better understand the basic mechanisms
of this process so that specific and effective cancer therapeutics can be developed. A critical gap in the
literature is the spatial context of modified transcripts; many studies use RNA from whole cells and may miss
key mechanisms by averaging the effects of RNA modifications across the transcriptome. I will bring a new
perspective to RNA modification biology by focusing my work on a single subcellular context: the paraspeckle.
Paraspeckles are stress-inducible nuclear bodies that are assembled on the lncRNA NEAT1, and both this
transcript and the paraspeckle itself have been implicated in human cancers. I have used mass spectrometry
and sequencing to identify novel RNA modifications on NEAT1, and I hypothesize that these and other
modifications on NEAT1 contribute to the assembly of functional paraspeckles. Critically, my preliminary results
indicate that the modification profile of NEAT1 differs between cell lines, so I will perform experiments in lines
from two cancers marked by overexpression of NEAT1 and one where NEAT1 is downregulated, so that I can
look for common mechanisms as well as patterns in the differences between them. In Aim 1, I will focus on
NEAT1 directly. I propose the expansion of my current mass spectrometry and sequencing methods so that I
can assemble a more complete map of RNA modifications on NEAT1, including the validation and
quantification of modifications at single-base resolution. I will mutate identified modification sites, then measure
the effects on NEAT1 stability and isoform distribution by qPCR and effects on protein interactions through
crosslinking and proteomic analysis. In Aim 2, I will investigate the paraspeckle. I will use both an unbiased
genome-wide screen using a paraspeckle reporter system and a targeted microscopy screen of known RNA
modification enzymes to identify novel regulators of the paraspeckle. I will make catalytically inactive mutants
of the top hits from these screens and perform modification-sensitive RNA sequencing to determine whether
these enzymes are modifying NEAT1, other components of the paraspeckle, or upstream regulators, and use
fluorescence recovery after photobleaching to measure modification-specific changes in paraspeckle
dynamics. Together, these aims will discover and characterize RNA modifications that have a role in
paraspeckle formation, revealing insights in an unexplored area of RNA cell biology.

Public health relevance
PROJECT NARRATIVE Chemical modification of RNA is often misregulated in cancer, and whether the modifications promote or suppress cancer progression can be specific to the cell-type and transcript. My work focuses on the long noncoding RNA, NEAT1, and the nuclear body that it scaffolds, the paraspeckle, which have been studied in a cancer context for over a decade but only recently examined for RNA modifications. My preliminary data reveals unexplored, cell-line specific RNA modifications on NEAT1, and my proposed research will map and determine the function of these and other RNA modifications on NEAT1 and the paraspeckle in cancer lines with characteristic over- or under-expression of NEAT1.